Scientific/Technical Core

The Scientific and Technical Core (SC) aims to catalyze innovative, impactful research in population health
and, in doing so, increase affiliates’ competitiveness for external funding at all career stages, but in particular
for junior scholars. The SC achieves this goal by providing access to state-of-the-art infrastructure, training,
and consultation. Infrastructure involves access to core computing services (e.g. software, REDCap for
surveys), custom-build architectures to meet needs expressed by multiple affiliates (e.g. secure postgres
database servers), access to high performance/distributed computing, and support for the Northwest Federal
Statistical Research Data Center and The UW Data Collaborative, which provides access to innovative,
sensitive data in a virtual environment. The SC also maintains modern laboratory facilities for biodemography
research and plans to substantially expand capacity as part of this renewal. Training consists of workshops
made available to the broader community via Zoom and CSDE’s YouTube channel. Expert consultation is
available in (i) data management, security and reproducibility, (ii) statistical demography, (iii) biodemography,
and (iv) spatial demography, with a proposal in this renewal to substantially expand expertise in computational
demography and survey methodology, while further deepening strength in biodemography. The SC also
coordinates with the Development Core (DC) to ensure support and expertise match with ongoing DC
programs, particularly for junior affiliates.